Diabetic Foot Ulcer Wound Fluid Biomarker

The 2020 CDC national diabetes statistics report identified that 34.2 million Americans, or 10.5% of the
population had diabetes in 2018. It is estimated that over the course of their lifetime up to a third of these people
with diabetes will develop a diabetic foot ulcer (DFU). The five-year mortality and direct costs of care for people
with diabetic foot complications are comparable to cancer. Approximately 40-60% of nontraumatic lower limb
amputations worldwide are caused by diabetic complications, and 80% of these amputations follow DFU. In
patients with hard-to-heal DFUs, treatment with multiple therapies is often necessary to manage stubborn
wounds. The current DFU treatment algorithm uses failure to improve (>50% wound area reduction) after four
weeks of standard of care (SoC) therapy to make a clinical decision on changing the therapy. The lack of
objective early indicators of wound healing outcomes handicaps DFU care strategy. Biomarkers that predict non-
healing (i.e., refractory to SoC) would provide an objective basis for rationally adopting alternate treatment
regimen to wound care providers in a timely manner. This proposal rests on our premise that non-healing diabetic
wounds would suffer from metabolic impairments which in turn would be reflected by changes in metabolites
contained in wound fluids (WF). A metabolomics approach was used to screen 578 metabolites from 161 WF
from chronic wound patients. Of all these metabolites, ONE PARAMETER emerged as a robust predictor of non-
healing: low Cysteine (Cys)/Cystine (CysS). A prospective preliminary study on DFU patients (N=24) showed
that low Cys/CysS in WF predicts non-healing. A point-of-care microtiter-plate (standard hospital assay platform)
based test was used. Because the proposed work seeks to establish Cysteine Redox as a biomarker of non-
healing or Open wound, the study is named CREDO. The R61 preparatory phase is named 2CREDO (towards
CREDO), and the R33 phase is referred to as CREDO. Aim 1: Validate the use DFU wound fluid low Cys/CysS
ratio (<3.43 cut-off) as a primary biomarker to predict non-healing of DFU. Aim 2: Develop a complete clinical
protocol to validate the use of Cys/CysS ratio in wound fluids to predict the healing of adult DFU. Aim 3: Conduct
a multi-center clinical study of diabetic foot ulcer patients to perform detailed validation of wound fluid based
Cys/CysS ratio as a biomarker to predict diabetic foot ulcer healing. Aim 4: Initiate discussions with FDA to
establish Cys/CysS as a clinical biomarker to predict DFU healing. The proposed work will be conducted as
ancillary Study of the current NIDDK Diabetic Foot Consortium (DFC) who have approved feasibility of our
protocol.

Public health relevance
Project Narrative Diabetic foot ulcers (DFU) are a common reason for hospitalization of diabetic patients and frequently results in amputation of lower limbs and loss of lives. The proposed project is based on the study of DFU patients and aims to establish a robust, reliable biomarker for predicting DFU non-healing.